The neurobiology of two distinct subtypes of neurodegenerative apraxia of speech: phenotypes of Alzheimer disease related 4-repeat tauopathies

PROJECT SUMMARY
Progressive apraxia of speech (PAOS) is a devastating neurodegenerative syndrome that ultimately shortens
lifespan and is most commonly due to an Alzheimer’s disease related disorders (ADRD) four-repeat tauopathy.
Nine years ago, we described two distinct subtypes of PAOS: phonetic PAOS characterized predominantly by
articulatory distortions and prosodic PAOS characterized predominantly by slow speech rate and abnormal
prosody. In the 1st cycle we demonstrated that speech, language, and neurological features differ across
PAOS subtypes which helped to validate these subtypes as being distinct. We performed cross-sectional
analyses including voxel-based morphometry of structural MRI, diffusion tensor imaging and 18F-
fluorodeoxyglucose PET (FDG-PET) and found evidence for greater cortical involvement in phonetic PAOS.
Leveraging autopsy data, we also demonstrated that the PAOS subtypes are associated with specific 4-repeat
tauopathies (phonetic with corticobasal degeneration and prosodic with PSP) and have neuronal loss in distinct
cortico-striatal and pallido-nigro-luysial-cerebellar regions. However, there are still many gaps in knowledge.
Little is known about progression, and whether longitudinal rates of clinical progression differ in PAOS
subtypes, whether anatomic and metabolic rates differ and can be detected with advanced neuroimaging
techniques, and whether genetic and histopathologic features of iron, Alzheimer disease neuropathologic
changes or other co-pathologies play any role in PAOS subtypes. In the 2nd cycle we will proceed in new
directions to address these knowledge gaps and limitations using data collected from 120 PAOS patients
including 47 patients from the 1st cycle. In Aim 1, we will determine whether rates of decline in speech and
other communication features, including acoustic characteristics derived from a novel rate modulation task, or
time to the development of clinical outcomes, are associated with subtype. This aim will be critical to aid
diagnosis and prognostication of disease progression. In Aim 2, we will determine whether advanced and
novel neuroimaging techniques can detect regional longitudinal differences and whether imaging differences
correlate with differences in clinical change over time, across PAOS subtypes. We will analyze structural MRI,
FDG-PET and quantitative susceptibility mapping (QSM) to assess volume, metabolism, and iron deposition.
This aim will improve understanding of how differential involvement of these regions relate to PAOS subtypes
and provide specific neuroimaging biomarkers for diagnosis and disease tracking which is also important for
clinical trials. In Aim 3, we will determine the relationship between tau- and Alzheimer disease related genetic
risk alleles, regional iron burden, Alzheimer disease neuropathologic changes, and other co-pathologies, and
PAOS subtype. Results from this aim will improve our understanding of the neurobiology of PAOS subtype.
Achieving the aims of the 2nd cycle will have significant clinical relevance to every speech-language pathologist
and neurologist who diagnose and care for patients with speech and language disorders.

Public health relevance
PROJECT NARRATIVE We have described two different subtypes of progressive apraxia of speech (PAOS), known as the phonetic and prosodic subtypes, and in cycle 1 of this grant prove that there are important differences at presentation between the subtypes, as well as different associations with two Alzheimer’s disease related tauopathies. In cycle 2, we plan to study 120 patients with PAOS, follow those who are living over time to see how the disease evolves, perform new types of brain scan techniques, and study the largest collection of autopsied brains on PAOS to better understand how brain damage relates to subtype. Knowledge gained from cycle 2 will help to improve diagnosis, provide patients with useful information to help them better prepare for the future, and help to explain the cause of PAOS.